EPIDEMIOLOGY SHARED RESOURCE

The Epidemiology Shared Resource (ESR) supports the patient data access and consulting needs of Fred Hutchinson/University of Washington Cancer Consortium (Consortium) investigators who conduct population-based studies of the etiology, treatment, psychosocial sequelae, and prognosis of cancer. The ESR achieves this aim primarily by providing access to, and scientific expertise about, population-based data on cancer diagnoses collected by the Cancer Surveillance System of western Washington (CSS). The ESR provides the infrastructure to coordinate access to the CSS, to develop policies and procedures for use of its confidential patient information, and to implement informatics tools that enhance the ability of investigators to conduct research on population-based series of cancer patients.